The GAIN (Greater Access and Impact with NAT) Study: Improving HIV Diagnosis, Linkage to Care, and Prevention Services with HIV Point-of-Care Nucleic Acid Tests (NATs)

Project Summary/Abstract
This is a critical time for the advancement of HIV prevention and care. In the U.S., testing has become
widespread, and most persons who are living with HIV (PLWH) are aware of their status. Antiretroviral therapy
(ART) has become so simple and tolerable that most PLWH can achieve “undetectable” HIV levels, reaping
benefits for their own health and becoming “untransmittable” to their partners. Pre-exposure prophylaxis (PrEP)
is a safe and efficacious method of reducing HIV acquisition. However, the point-of-care (POC) HIV tests that
are FDA-approved still fail to recognize highly infectious persons with acute infection, and real-time adherence
counseling options for HIV treatment and PrEP are limited. HIV continues to have disproportionate impact
among men and transgender persons who have sex with men, with subpopulations like racial/ethnic minorities
and methamphetamine-users being at particularly high risk. Thoughtful implementation of POC nucleic acid
tests (NAT) has potential to address some of the remaining challenges in HIV prevention and care.
The project proposed for this Cooperative Agreement (U01) will develop, implement, and evaluate models for
use of POC NAT among HIV-negative persons seeking HIV testing, PEP, and PrEP and HIV-positive persons
in community and clinical settings. Following a period of formative work to establish protocols, SOPs, data
collection instruments, and data analysis plans, Aims #1 and #2 will evaluate the sensitivity and specificity of a
qualitative POC NAT in persons not known to be HIV-positive and will determine the impact of its use on PrEP
uptake and persistence among persons testing HIV-negative and on time to HIV continuum of care outcomes
among persons testing newly HIV-positive. Aim #3 will implement a POC NAT-tailored behavioral intervention
to evaluate impact on time to virologic suppression among PLWH receiving ART. Aim #4 will quantify the
acceptability and feasibility of implementation of POC NAT in community and clinical settings and collect cost
and related data for cost-effectiveness analyses. Finally, in Aim #5, a distinct but related study will compare the
sensitivity, specificity, and agreement of multiple POC NATs over a range of HIV RNA levels.
This project will collect data on the performance of POC NAT and associated clinical outcomes, patient and
provider perspectives regarding acceptability and feasibility, and implementation science outcomes including
cost effectiveness. Employing a research team with substantive expertise in HIV testing including POC NAT,
PrEP and HIV clinical care and programming, community and public health expertise, medication adherence
interventions, and cost-effectiveness analysis, this collaboration will work to implement POC NAT with the goal
of documenting real world test performance and developing models to improve HIV care and prevention
outcomes in the U.S.

Public health relevance
Project Narrative Point-of-care (POC) nucleic acid tests (NATs) have the potential to improve real-time diagnosis of acute HIV infection and monitoring of antiretroviral therapy among persons living with HIV. There are limited data on use of POC NAT in the United States and no information regarding implementation. This project will implement the use of POC NAT in a variety of populations in community and clinical settings with the goal of documenting real world test performance and developing models to improve HIV care and prevention outcomes in the U.S.